Supplement to Structure and function of nucleotide sugar transporters.

Project summary (from original application)
Nucleotide sugar transporters (NSTs) are a family of proteins that are a critical part of the glycosylation
machinery in all eukaryotes as they are responsible for transporting nucleotide sugars from the cytoplasm,
where they are synthesized, into the Golgi lumen where they are then utilized by glycosyltransferases to
glycosylate proteins and lipids. NSTs provide an additional essential role of transporting the nucleotide
monophosphate byproduct of the glycosyltransferase reaction, which is inhibitory towards
glycosyltransferases, back to the cytoplasm where it can be recycled. Since NST activity controls the
concentrations of both nucleotide sugars and nucleotide monophosphates in the Golgi lumen, disruption of
NST activity can have many adverse physiological effects as is seen in a number of diseases caused by
either mutations in NST genes or dysregulation of NST activity. However, selective inhibition of NSTs also
has the potential to be exploited for therapeutic benefit in targeting parasites that depend on particular
glycoconjugates for virulence as well as in blocking certain glycosylation patterns that promote tumor
metastasis. Our long-term goal is to understand the molecular details that underlie substrate recognition,
substrate selectivity, and the mechanism of transport of NSTs. Although NSTs were first described nearly
four decades ago, many of these questions remain largely unanswered, primarily due to a lack of structural
information for NSTs as well as limited methods for biochemical characterization of this family of proteins. To
overcome these obstacles, we have developed methods to express, purify, and crystallize a mammalian
NST, the mouse CMP-sialic acid transporter (CST). We have also developed novel binding and transport
assays that will allow us to address questions regarding substrate recognition and selectivity. These methods
will allow us to determine high- resolution structures of CST in complex with its substrates CMP and CMP-
sialic acid, as well as structures that represent different states of the transport cycle. These structures
combined with biochemical studies will answer the fundamental questions regarding the structure-function
relationship of NSTs, which will further our understanding of the role NSTs play in physiology and aid in the
development of drugs to target NSTs.

Public health relevance
Project narrative (from original application) Nucleotide sugar transporters (NSTs) transport nucleotide sugars from the cytoplasm, where they are synthesized, into the Golgi lumen where they are then utilized by glycosyltransferases to glycosylate proteins and lipids. NSTs are critical components of the glycosylation machinery in all eukaryotes and their dysregulation forms the basis for many diseases, yet they also represent novel therapeutic approaches for targeting pathogenic parasites or tumor metastasis. The goal of this proposal is to gain a comprehensive understanding of the structure-function relationship of NSTs through high-resolution structure determination and biochemical studies, which will further our understanding of the role of NSTs in physiology and aid in the development of drugs to target NSTs.